Analytics Core

Abstract
The Analytic Core will process and harmonize multi-omics and multimodal endophenotype data, and provide
advanced computational systems biology methods and frameworks for data integration and analysis for the
entire project. Our multidisciplinary team has substantial expertise in multi-omics data analysis, data
harmonization, computational method development, multi-omics data integration, genetic association analysis,
neuroimaging analysis, data visualization, biostatistics, and network analysis. The Core will support collaborative
work of the U19 project by providing processed multi-omics and multimodal phenotype data and enhancing the
interoperability of analysis methods and pipelines. Furthermore, the Core will work closely with the Administrative
Core to curate and share newly generated data and to provide documentation of data processing for public
access. The overall goal of the U19 is to identify and validate centrally-linked longitudinal peripheral biomarkers
of Alzheimer’s disease (AD) in multi-ethnic populations by integrating longitudinal multi-omics and multimodal
phenotypes from eight independent cohorts. To achieve this goal, harmonized high-quality processed data and
advanced computational and systems biology methods and pipelines for data analysis are critical to the entire
project. First, the Analytic Core will provide high-quality and harmonized high-throughput multi-omics data from
blood and brain tissue and multimodal neuroimaging, cognitive and postmortem neuropathology data. This data
will permit analyses connecting peripheral and central changes within and across clinical, community-based and
multi-ethnic cohorts and samples. The Core will also implement and provide advanced computational, systems
biology frameworks for high-dimensional data analysis, enabling investigators from all three projects to perform
data integration and analysis. To this end, the Analytic Core will be comprised of five teams: Omics, Imaging,
Clinical, Neuropathology, and Computational and Systems Biology teams. The Analytic Core will focus on new
data processing and integrative analysis framework development of longitudinal multi-omics data in relation to
longitudinal multimodal endophenotypes. In Aim 1, we will assemble and provide state-of-the-art pipelines for
processing high-dimensional multi-omics from blood and brain tissue and multimodal neuroimaging data, as well
as clinical, cognition and neuropathology phenotypes for all projects. In Aim 2, we will implement and provide
advanced multi-omics and multimodal endophenotype data integration and analysis approaches and pipelines
for the entire project, which include but not limited to (1) novel systems biology and deep learning platforms for
identification of blood molecular signatures that are associated with molecular signatures in the brain; (2)
network-guided integrative analysis methods for multi-omics data integration to predict disease progression; and
(3) an advanced system for query, analysis, and visualization in systems biology. The Core will work closely with
the other Cores and Projects to enable analysis of multi-omics and AD phenome data for each components’
specific needs.